Neuroinflammation in Cerebral Small Vessel Disease using PET/MR Imaging

Project Summary/Abstract
Vascular contributions to cognitive impairment and dementia (VCID) is the second leading cause of dementia
and a major contributor to Alzheimer’s disease (AD), the leading cause of dementia. VCID is mainly caused by
cerebral small vessel disease (CSVD). Thus far, the pathophysiology underlying CSVD has not been well-
understood. Vascular risk factors, including hypertension, hyperlipidemia, and diabetes mellitus, may lead to
injured arterioles, impaired autoregulation, chronic hypoxia/ischemia, blood brain barrier (BBB) impairment, and
neuro-inflammation. Several lines of evidence, including results from animal models, post-mortem human brain
neuropathology, and systemic inflammatory biomarkers studies, implicate the independent contribution of
neuroinflammation in the pathogenesis of CSVD and resulting VCID. However, direct evidence of
neuroinflammation in patients with CSVD is still lacking. Sphingosine-1-phosphate receptor subtype 1 (S1PR1)
is involved in cell trafficking and lymphocyte/macrophage recruitment. Previous studies have demonstrated that
S1PR1 was highly expressed and colocalized with microglia and astrocytes in a mouse model of multiple
sclerosis (MS). The S1P-modulator, FTY720 (fingolimod), approved by the FDA, has been widely used for
treating MS due to its ability to antagonize S1P receptors functionality. An 11C-CS1P1 PET radiotracer with high
affinity and selectivity for S1P1 has been recently developed and validated in animal models and post-mortem
human specimens at our institution. The FDA recently approved an eIND application (IND 146548) for the first
human PET imaging of this 11C-CS1P1 radiotracer. We have completed a safety and dosimetry study in normal
participants, demonstrating that 11C-CS1P1 PET is safe and ready for patient studies. The goals of this
exploratory study are to 1) demonstrate that S1PR1 expression is elevated and colocalize with microglia and
astrocytes in post-mortem brain specimens from deceased patients with underlying CSVD. 2) Determine if
neuroinflammation measured by 11C-CS1P1 uptake is independently associated with CSVD structural endpoints
using in vivo PET/MR imaging. Successful completion of this study will provide both ex vivo and in vivo evidence
of neuroinflammation in CSVD. This study will lay the foundation to identify patients who may benefit from therapy
targeting neuroinflammation to reduce CSVD injury and dementia in the future.

Public health relevance
Project Narrative Cerebral small vessel disease (CSVD) is the leading cause of vascular contributions to cognitive impairment and dementia (VCID). Thus far, the pathophysiology underlying CSVD has not been well-understood. Several lines of evidence suggest neuroinflammation’s potential contribution to the pathogenesis of CSVD and resulting VCID. However, direct evidence of neuroinflammation in patients with CSVD is still lacking. In this study, we propose a novel PET radiotracer for in vivo imaging of neuroinflammation. We will provide ex vivo evidence of neuroinflammation in CSVD using post-mortem neuropathology. Moreover, we will determine whether neuroinflammation independently predicts CSVD severity using in vivo PET/MR imaging. The proposed research is relevant to public health as it has a significant impact on patients with vascular dementia. If successful, this study will lay the foundation to identify patients who may benefit from therapy targeting neuroinflammation to reduce CSVD injury and dementia in the future.